Listening to and Learning from Disfluent Speech in Children with and without Developmental Language Disorder

PROJECT SUMMARY/ABSTRACT
Developmental language disorder (DLD) impacts 7% of all children—both monolingual and bilingual—
and has lifelong consequences for educational attainment and socioemotional wellbeing. DLD is characterized
by deficits in structural language, but the mechanisms underlying these deficits remain under investigation. The
Predictive Processing Hypothesis posits that prediction underlies human cognition and behavior, and it is
increasingly being applied to language. Recent work has applied the Predictive Processing Hypothesis to DLD,
investigating the possibility that deficits in predictive processing underlie language deficits. However, this
hypothesis has only been tested in monolinguals, and only within the context of fluent, idealized language input.
Fillers (e.g., uh and um), are a common disfluency in spontaneous language production and reliably precede
difficult-to-retrieve words (e.g., words that are low-frequency). Neurotypical monolingual adults harness this
association between fillers and production difficulty to anticipate upcoming novelty, but the mechanisms that
underlie children’s comprehension of fillers as signals for upcoming difficult words are poorly understood. This
is particularly so for children who have DLD and/or are exposed to more than one language (bilingual children).
The overarching goal of this proposal is to examine both comprehension of fillers and consequences
for learning in monolingual and bilingual children with and without DLD. A total of 80 children (40 English
monolinguals and 40 Spanish-English bilinguals) ages 4-5, representing the full range of language ability (from
DLD to typical language) will participate. The Specific Aims are: 1.) to determine the impact of disfluencies on
language processing and learning in monolingual children with and without DLD and 2.) to determine the impact
of disfluencies on language processing and learning in bilingual children with and without DLD. Two eye-tracking
visual world tasks, in which children view novel and familiar objects side-by-side, will be used to assess predictive
processing of fillers and word learning under fluent and disfluent conditions. Language ability (from typically
developing to DLD) will be examined continuously under both aims, and bilingualism (proxied by years of second
language exposure) will be examined continuously under Aim 2. Together, the findings across the two aims will
test the innovative Predictive Processing Hypothesis within the novel context of disfluent speech and assess
how consequences of disfluency on processing scale up to impact learning. Moreover, the findings will provide
clinical insight into input characteristics that may enhance or disrupt learning and processing, with implications
for structuring interventions. During the training period, the applicant will acquire new knowledge in the language
profiles of bilingual and monolingual children with DLD as well as methodological considerations for working with
this population; gain critical background knowledge in fluency and disorders; develop expertise in eye-tracking
and advanced statistical analysis; and learn and practice principles of ethical science and effective mentorship.

Public health relevance
PROJECT NARRATIVE Language deficits have cascading consequences for educational, vocational, and social outcomes. However, it is unknown how deficits in language influence processing of disfluent speech, which accounts for 6% of children’s input. Therefore, this project examines how monolingual and bilingual children with and without developmental language disorder understand and learn from disfluent speech, with an aim toward extending existing theories and interventions to diverse populations and naturalistic linguistic contexts.